DISSEMINATION & TRAINING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Dissemination of our results and training in our technologies are essential to the success of the NAC. Each year, researchers come to us for training in the Core technologies. Trainees have included medical and engineering undergraduates and postgraduates, software developers, and those writing applications based on software developed by the NAC.